Targeting Notch2 in Hematopoietic Cell Therapy.

R01HL103827-06A1 Resubmission (Zhou, Lan) 10.22.2018
Abstract
Hematopoietic stem cell (HSC) transplantation is the only curative option for various malignant and a
few nonmalignant diseases. A successful outcome is dependent on infusing an adequate number of
functionally active mobilized hematopoietic progenitor cells (HPCs). Inadequate mobilization in patients
showing poor responses to current mobilizing agents remains a clinical problem. In addition,
transplantation using lower-then-desired doses of stem cells increases risks of stem cell engraftment
failure. Hence, developing more efficacious and low-risk HPC mobilization regimens and strategies will
greatly improve patient outcomes. We recently identified a novel role of Notch as a cell surface
adhesion as well as signaling molecule to retain stem cell in the bone marrow microenvironment. Notch
is a conserved cell surface receptor that regulates stemness, growth, and differentiation. Notch
transactivation is the result of functional engagement of Notch receptors with Notch ligands, which is
dependent on the posttranslational modification of Notch receptors with O-fucose and Fringe on the
epidermal growth factor (EGF) modules of Notch extracellular domain. Structural studies have
demonstrated that O-fucose attached to the specific threonine residue of the core ligand binding region
of Notch EGF repeats functions as a surrogate amino acid to make specific and functional contact to
Notch ligand DLL4 and JAG1, respectively. Elongation of O-fucose to a disaccharide (GlcNAcβ1-
3Fucose) by Fringe further increases Notch binding affinity to some Notch ligands. In the last funding
cycle, we identified conservative Notch-ligand adhesive interaction and its modification by O-
fucosylation for HSC quiescence and niche maintenance. We provided compelling evidences showing
that deficiency of O-fucosylation leads to decreased HSC quiescence and HSC adhesion to bone
marrow niche cells, and increased HSC egress from the marrow. We also reported that neutralizing
DLL4 or JAG1 as well as blocking Notch2 significantly enhances HSC egress to the periphery. More,
recently, we found transient Notch2 blockade results in superior engraftment and hematopoietic
recovery of mobilized HSPC associated with enhanced HSPC activity and attenuated ER stress
activation. Further, we found that Fringe-modified recombinant Notch peptides bearing the core ligand
binding EGF repeats function as decoys for Notch ligand to induce HSC and progenitor cell egress in
osteoblastic spheroids. We thus hypothesize that Notch2 interaction with DLL4 or JAG1 regulates
ligand- and niche-specific HSPC retention. We further hypothesize that Notch2-targeted mobilization
regimen may improve HCT outcome by mitigating ER stress response activation. We will test this
hypothesis in three aims. In Aim 1, we will examine the differential roles of JAG1 and DLL4 expressed
by the endothelial and the immature osteolineage cells in the regulation of HSC niche retention,
location and mobilization. In Aim 2, we will assess the ligand binding affinity and the efficiency of
Fringe-modified Notch peptides as decoys to enhance HSPC egress from HSC niche. In Aim 3, we will
examine the significance and the mechanism by which blocking Notch2 potentiates HSPC activity
through attenuating ER stress response. At the end of this study, we hope our findings will reveal novel
aspects of Notch signaling in HSC niche biology and in ER stress regulation which may provide a
resource for understanding Notch signaling in the control of HSC activity during stress hematopoiesis,
with implications for identifying ways to improve HCT outcomes.

Public health relevance
R01HL103827-06A1 Resubmission (Zhou, Lan) 10.22.2018 Project Narrative / Health Relevance Hematopoietic stem cell (HSC) transplantation is the only curative option for various malignant and a few nonmalignant diseases. A successful outcome is dependent on infusing an adequate number of functionally active mobilized hematopoietic progenitor cells (HPCs).We hope the proposed studies will determine if a novel mobilizing approach by including reagents that target Notch2 would result in improved mobilization with superior engraftment compared to the current regimen in stem cell therapy.